Ophthalmology Core Facility

OVERALL CORE PROJECT SUMMARY
This P30 Ophthalmology Core Facility provides ongoing support for NEI-funded Oregon Health and Science
University (OHSU) and Casey Eye Institute vision researchers. The four resource cores are: Bioimaging &
Confocal Microscopy; Gene Expression & Manipulation; Genetic Models of Ocular Disease & Biostatistics; and
Proteomics. These shared resources will provide equipment and personnel otherwise not available to individual
researchers working in a wide range of vision-threatening diseases, including cataracts, glaucoma, macular
degeneration, diabetic retinopathy, uveitis, pediatric eye disease, the physiology of vision and the genetics of
glaucoma, macular degeneration, uveitis and inherited retinal diseases. The Bioimaging & Confocal Microscopy
core will support confocal microscopy studies using state-of-the-art instrumentation for identification and high-
resolution localization of proteins. In addition, this core will continue to support small animal imaging through
maintenance of a Micron IV Retinal Imaging Microscope for in vivo imaging of rodent eyes. The Gene Expression
& Manipulation core will provide instrumentation and technical support for a range of molecular methods to
identify changes in levels of gene expression and proteins, and for methods by which these responses can be
manipulated, such as RNAi silencing, gene overexpression or gene editing by CRISPR/Cas9. The Genetic
Models of Ocular Disease & Biostatistics core (formerly Molecular Genetics & Biostatistics) will continue to
provide DNA isolation services from patient blood samples, saliva and tissue and provide access for NEI
investigators to advanced statistical techniques to ensure use of appropriate methods both in study design and
for data analysis. Biostatistical services include analysis of complex gene expression arrays and RNA-seq
datasets, large proteomics studies, optical coherence tomography (OCT) and OCT angiography studies and
large patient population data sets from bioinformatics and clinical research studies. Two new services will provide
(1) genotyping of cell, tissue and biological samples from human, non-human primate, rat, mouse and pig tissues
and (2) provide assistance in establishing primary cell cultures from ocular tissues, as well as fibroblasts from
patients with ocular disease. Offering these new services will enable functional genotype-phenotype studies for
ocular disease, a critical enhancement in the current age of precision medicine. The Proteomics core will provide
access to advanced, high-throughput techniques for measuring changes in protein abundance and modification
with disease, determining how proteins fold and interact with one another, and how they regulate development.
All four cores are highly complementary and, in combination with new programs designed to encourage
communication between clinicians and basic scientists, will increase discoveries with greater direct benefit to
patients.

Public health relevance
PROJECT NARRATIVE: OVERALL COMPONENT This is a core grant (“Ophthalmology Core Facility”) to the Oregon Health and Science University (OHSU) Casey Eye Institute to fund four service cores and support vision researchers studying a wide range of blinding diseases. These entail shared, sophisticated instrumentation and expertise that would be unobtainable by individual researchers. These cores consist of (1) high magnification imaging of proteins in tissue samples and live-imaging technologies for small animal models; (2) methods to detect gene expression within tissues and methods to activate or suppress them to understand how they contribute to eye disease; (3) methods that will help investigators discover gene alterations in patient and model samples and cell cultures, as well as sophisticated statistical expertise to analyze complex gene and population data sets; and (4) methods for detecting protein composition in eye tissues and how they are altered in normal and diseased eyes.